Targeting the functions of the gonococcal Type lV pilus

PROJECT SUMMARY
Neisseria gonorrhoeae (Gc) is the sole causative agent of the sexually transmitted infection
gonorrhea. The rapid raise in antibiotic resistance coupled with a recent sharp increase in
reported cases in the U.S. have made this organism a target for the CDC, WHO and NIH. This
proposal will focus on the Gc Type IV pilus (T4p), which is an essential colonization and
virulence factor. We will determine how the T4p helps to protect Gc from polymorphonuclear
leucocyte (PMN) killing by altering iron homeostasis within the bacterial cell. Additionally, we will
perform a small molecule screen to identify molecules that can inhibit a protease necessary for
Gc T4p elaboration to develop novel pharmacologic agent for research and set the stage for the
possibility for new types of compounds that act against Gc and possibly other pathogenic
bacteria.

Public health relevance
PROJECT NARRATIVE Gonorrhea remains an important public health issue that shows increasing rates and alarming antibiotic resistance. This work will determine mechanisms used by the bacterium that causes gonorrhea to resist killing by white blood cells recruited to the site of infection. The work will also identify and validate chemicals that could inhibit the bacteria's ability to infect.